Flow Cytometry (FLOW)

The Flow Cytometry Shared Resource (FLOW-SR) was established in 1984 and has been continuously funded
by the University of Michigan (U-M) Rogel Cancer Center (Rogel) since 1988. While FLOW-SR is available to
all U-M faculty, it has been heavily utilized by Rogel members throughout its history. It is well recognized that
flow cytometric analysis and cell sorting are critical for measuring a variety of cellular biomarkers and
processes in cancer-related life science disciplines including cell biology, immunology, biochemistry, genetics,
and pharmacology. Thus, FLOW-SR is highly relevant to Rogel Research Programs.